Derivation of lung epithelia from iPS cells for advanced disease modeling

Project Summary/Abstract
Diseases affecting the lung parenchyma or alveoli cause significant morbidity and mortality in the US
today. Treatments for these diseases are often ineffective and the development of novel therapeutics is
hampered by an incomplete understanding of disease pathogenesis due in part to an inability to access
living alveolar cells from patients. The derivation of an inexhaustible supply of patient-specific alveolar
epithelial and mesenchymal cells would allow studies of disease pathogenesis in primary-like cells
carrying each patient’s entire genetic background, and consequently the development of new
therapeutics. This application proposes to renew a long-standing project focused on the in vitro derivation
of lung lineages from patient-specific induced pluripotent stem cells (iPSCs) for disease modeling. In this
renewal we apply our diverse biobank of interstitial lung disease (ILD) patient-specific iPSCs that carry
mutations impacting alveolar type 2 cell (AT2) function. We proposed to differentiate these cells and their
gene-edited progeny into iPSC-derived AT2 cells (iAT2s) to test the hypothesis that a variety of distinct
upstream mechanistic drivers of AT2 dysfunction, including some that are epithelial-intrinsic and others
that rely on extrinsic paracrine epithelial-mesenchymal cross talk, converge in AT2 responses that are
shared and stereotypic, such as: a) canonical NFkB activation, b) dampened alveolar progenitor cell
function, and c) emergence of alveolar-basal intermediate (ABI) cell states; we hypothesize that these
convergent AT2 responses result in mesenchymal fibrogenic activation driven by targetable ligand-
receptor pairs. We test this hypothesis through 3 specific aims designed to: 1) identify aberrant iAT2
programs that are “epithelial-intrinsic”; 2) test the hypothesis that human dysfunctional iAT2s (regardless
of upstream driver) upregulate ABI cell states not from epithelial-autonomous mechanisms but rather in
response to multicellular “cross-talk” with other lineages, such as mesenchymal cells; and 3) define non-
intrinsic aberrant epithelial and mesenchymal programs that are initiated by AT2 dysfunction but rely on
epithelial-mesenchymal “cross-talk”.

Public health relevance
PROJECT NARRATIVE Lung diseases, such as pulmonary fibrosis, result in significant morbidity and mortality worldwide. The advent of stem cell discoveries and regenerative medicine presents new opportunities to improve our understanding of these diseases and to develop new treatment approaches. Here we propose to better understand the pathogenesis of and develop new therapies for interstitial lung diseases and pulmonary fibrosis, based on new in vitro models of disease that utilize patient- specific pluripotent stem cells.